Microscopy and Flow Cytometry Core

SUMMARY
The Microscopy and Flow Cytometry Core (MFCC) of the Center for Targeted Therapeutics (CTT) COBRE
provides cutting edge services and access to state-of-the-art equipment and infrastructure for flow cytometry
and advanced microscopy to interested investigators at the University of South Carolina (USC). The specific
capabilities offered by MFCC include confocal and fluorescent microscopy, live cell imaging, enhanced data
analysis capabilities, enhanced flow cytometry and cell sorting analyses, and assistance in experimental design
and data interpretation. So far, MFCC has provided services to more than 55 investigators, including CTT
members and other USC faculty, in a wide range of tasks related to advanced microscopy and flow cytometry
techniques. The goals of MFCC at Phase 3 are 1) To provide CTT investigators and other researchers at USC
with state-of-the-art capabilities in advanced microscopy, flow cytometry and cell sorting. 2) To train investigators
in state-of-the-art methodologies in advanced microscopy, flow cytometry and cell sorting and assist them in
applying these techniques to their specific research interests. 3). To develop and implement programs that will
enhance MFCC's sustainability in the long-term.